Mu opioid receptor-gated roles of glutamatergic and GABAergic ventral tegmental area neurons in fentanyl reward and relapse

PROJECT SUMMARY
Drug overdose deaths have surged more than fivefold over the last two decades, and more than 75% involve
opioids. Both rewarding aspects of drug use as well as the avoidance of aversive withdrawal symptoms
contribute to opioid addiction. A key question amidst the opioid epidemic is whether rewarding and aversive
aspects of opioid addiction can be leveraged to aid recovery in addicted individuals. Opioid drugs of abuse
exert their powerful addictive properties by exploiting the brain’s reward center, the ventral tegmental area
(VTA). Canonically, the rewarding effects of opioids arise through activation of μ-opioid receptors on VTA
neurons that release the inhibitory neurotransmitter γ-aminobutyric acid (GABA). Opioid binding on these
GABAergic neurons leads to increased dopamine release in the nucleus accumbens that is critical for opioid
reward and opioid-seeking. Surprisingly, we recently discovered μ-opioid receptor VTA neurons that release
the excitatory neurotransmitter glutamate. Contrary to the classically rewarding circuit governed by GABAergic
neurons, opioid binding on glutamatergic VTA neurons reduces excitatory drive onto dopamine neurons. My
preliminary data indicate that GABA release from μ-opioid receptor VTA neurons supports opioid-induced
reward, but glutamate release from μ-opioid receptor VTA neurons does not. Based on these findings, we ask
two questions: (1) Do glutamatergic or GABAergic μ-opioid receptor VTA neurons alone modulate nucleus
accumbens dopamine? and (2) Do glutamatergic or GABAergic μ-opioid receptor VTA neurons alone drive
opioid-seeking? We hypothesize that glutamatergic and GABAergic μ-opioid receptor VTA neurons differ in
their modulatory effects on the nucleus accumbens reward system and in their ability to drive opioid-seeking
behavior. In Aim 1, I propose to specifically activate μ-opioid receptors on glutamatergic or GABAergic VTA
neurons while measuring dopamine release in the nucleus accumbens in mice. In Aim 2, I will determine
whether selective μ-opioid receptor activation on glutamatergic or GABAergic VTA neurons drives opioid-
seeking in a model of relapse. The completion of these Aims will use cutting-edge techniques such as cell
type-specific pharmacology (DART), fiber photometry of dopamine sensors (GRABDA), and a
reinstatement/relapse paradigm of intravenous self-administration. The mentoring committee at the University
of Colorado Boulder, Colorado State University, and Duke University will provide expert guidance throughout
the study. I will receive significant training in intracranial microinjections and the methodology of DART,
intravenous self-administration and reinstatement paradigms, and the interpretation of GRABDA dynamics. The
findings of this study may redefine the neurobiological underpinnings of opioid-induced reward and relapse,
which will prove crucial in the continued struggle with the opioid epidemic.

Public health relevance
PROJECT NARRATIVE Opioid drugs of abuse exert their powerful addictive properties by activating opioid receptors in the brain’s reward center, the ventral tegmental area (VTA). Inhibitory VTA neurons classically drive opioid reward and opioid-seeking, but we recently discovered excitatory VTA neurons that surprisingly decrease reward signals in the presence of opioids. The proposed research will determine whether excitatory VTA neurons or canonical inhibitory VTA neurons alone are capable of influencing opioid reward and drive opioid-seeking.